Community-Engaged Development of a Peer Breastfeeding Support Intervention for Mothers with Opioid Use Disorder

PROJECT SUMMARY / ABSTRACT
The incidence of opioid use disorder (OUD) in pregnancy and neonatal opioid withdrawal syndrome are rapidly
increasing. OUD-exposed mother-infant dyads face increased medical and social risk in the perinatal period
and beyond. Breastfeeding significantly improves key health outcomes in OUD-exposed dyads and thus is
strongly recommended by national and international societies. Breastfeeding leads to reductions in mortality
and morbidity among opioid-exposed infants and life-long health benefits to both mothers and infants.
However, mothers with OUD are significantly less likely to initiate and continue breastfeeding than mothers
without OUD, many stopping in the first 1-2 weeks postpartum. This disparity persists because we lack
evidence-based, tailored services to support breastfeeding for OUD-exposed dyads, who face a complex web
of barriers to breastfeeding. Peer support has been utilized to support recovery in populations with SUD and to
support breastfeeding in other medically vulnerable populations. Despite the potential synergistic benefits of
providing breastfeeding peer counseling within a recovery care model among OUD-exposed dyads, this
strategy has yet to be described or tested. Further, the extent that breastfeeding may influence OUD recovery
is poorly understood. To address this gap, I propose to develop a peer lactation intervention for OUD-exposed
dyads leveraging a community-engaged approach. This project includes three main aims: (1) Engage mothers
with OUD to identify breastfeeding facilitators among mothers who breastfed ≥3 months in order to tailor
breastfeeding support, and to understand the potential influence of breastfeeding on recovery; (2) Facilitate
focus group conversations with perinatal OUD providers and clinical staff, community program staff, and peer
recovery and peer lactation counselors to identify environmental and organizational factors, skills, strategies,
and resources needed to adapt and implement a peer lactation model; and (3) Conduct a pilot single-site RCT
of 30 mothers with OUD with baseline peer recovery coaching to receive additional peer lactation support by a
counselor with lived OUD/breastfeeding experience vs. usual care (recovery coaching only) to examine
feasibility, acceptability, fidelity, and preliminary efficacy in breastfeeding and addiction outcomes. This
proposal directly fulfills NIDA’s priority area to “develop and test novel prevention, treatment, harm reduction
and recovery support strategies” through development of a breastfeeding support intervention with potential to
decrease morbidity and mortality among OUD-exposed dyads and provide foundational evidence on how
breastfeeding may impact OUD recovery. The PI, Dr. Standish, is an early-career clinician investigator, family
physician, and breastfeeding medicine physician who will use this career development award to enhance her
skills in community engaged approaches to research, participatory qualitative methods and clinical trial conduct
to carry out her stated career objectives and specific aims.

Public health relevance
PROJECT NARRATIVE Breastfeeding is strongly recommended for opioid-exposed mothers and infants due to the tremendous health benefits to the dyad; yet, mothers with opioid use disorder face significant barriers to breastfeeding due to a lack of tailored breastfeeding support services. This career development award will leverage a community- engaged approach to engage mothers, clinicians and community stakeholders in the design of a peer lactation support model for mothers with OUD. This will provide the basis for future studies of lactation support strategies that have the potential to improve lifelong health for opioid-exposed mothers and infants.